Environmental Sound Recognition Before and After Cochlear Implantation in Adults

PROJECT SUMMARY
Cochlear implants (CI) are the standard of care for adults with sensorineural hearing loss that is beyond the
therapeutic reach of hearing aids. Little is known about how current CI devices affect environmental sound recog-
nition (ESR), a nonspeech outcome domain that is crucial for the safety, independence, and quality of life (QOL)
for all CI users. Lacking robust evidence for how CIs affect ESR and the patient factors that influence ESR,
hearing health professionals are limited in their ability to offer ESR rehabilitation and evidence-based counseling.
This research study's investigators have found through pilot studies that ESR in postlingually deaf adults is
significantly reduced and highly variable compared to normal hearing peers. Preliminary cross-sectional and
longitudinal ESR assessments of environmental sounds presented in isolation – in contrast to context-rich
presentation of daily life – have demonstrated that experienced adult CI users do not uniformly outperform CI
candidates tested under best-aided conditions with hearing aids.
The current study has two Specific Aims: (1) to longitudinally quantify change in ESR for postlingual adults using
a novel context-rich ESR assessment to better approximate real-world everyday listening; and (2) to determine
the relative contribution of ESR to CI-specific QOL as reported by CI users. It is hypothesized that (1) context-
rich ESR will improve in adults following implantation, and (2) that ESR will contribute significantly to self-reported
CI-specific QOL. To test these hypotheses, a prospective, longitudinal assessment of ESR and CI-specific QOL
will be performed pre-CI through the first year of cochlear implantation in a sample of postlingual adults.
The expected benefits of this study are that hearing health professionals will be able to (1) provide patients with
evidence-based ESR predictions, (2) develop a more comprehensive understanding of the contributions of CI-
specific QOL beyond speech perception, and (3) lay the groundwork for future ESR rehabilitation strategies for
CI users who struggle in this important, overlooked CI outcome domain.

Public health relevance
PROJECT NARRATIVE Hearing loss is a major public health concern and cochlear implants (CIs) are the standard of care for hearing loss beyond the therapeutic capabilities of hearing aids. Very little is known about how well adults with CIs recognize everyday nonspeech environmental sounds, which are crucial for safety and independence. The proposed research aims (1) to test how well adult CI users identify environmental sounds and (2) to identify the degree to which environmental sound recognition contributes to quality of life with CIs in adults.